Enhancer AAV-based genetic access and manipulation of specific brain cell types implicated in aging and Alzheimer's Disease

Project Summary / Abstract
Alzheimer disease (AD) is the most prevalent type of age-progressive dementia, significantly affecting many
individuals aged 65 and older. Recent studies have uncovered disease relevant cell types and neural circuits in
the AD brains including humans and animal models and have identified molecular and functional alterations in
specific neuronal and non-neuronal cell types in aging and AD. New investigations that target and manipulate
specific brain cell types that are selectively affected by aging and AD progression could lead to major
breakthroughs in understanding the cellular and neural mechanisms underlying aging and AD/ADRD.
Genetically engineered viral vectors, including adeno-associated viruses (AAVs), are increasingly important
neurobiological tools for cell-type-specific neural circuit mapping and genetic payload delivery. AAV vectors that
incorporate gene regulatory elements in the viral genomes (enhancer AAVs) have been developed recently to
target specific types of neurons and other brain cell types for neural circuit analysis in the mouse and non-human
primate models. Of note, almost all of this work has been done in young adult animals, thus their performance
and feasibility needs to be established before they can be properly used in aging and AD neuroscience research.
In response to RFA-AG-25-024, we propose to leverage our recent technological advances to optimize and
develop cell-type-selective enhancer AAVs for genetic access to diverse cell types and their related neural circuit
analysis in multiple AD mouse models. Our guiding hypothesis is that brain cell-type-specific enhancers can be
further optimized and developed to study disease relevant cell types and neural circuits in the brain environments
of aging and AD animals. We will test our hypothesis that both vulnerable neuronal cell types and non-neuronal
cell types including oligodendrocytes and vascular cells are critically implicated in AD pathogenesis and
progression. In the R61 phase, we propose to screen newly developed enhancer AAV tools initially characterized
in healthy young adults and determine their effectiveness in targeting AD-relevant specific brain cell types in vivo
in older and degenerating brains. We will test and examine selected enhancer AAVs using different delivery
methods and different titers, and we will establish an optimized standard operating protocol for enhancer AAV
applications. In the R33 phase, we will use the optimized AAV-enhancer tools to monitor and manipulate brain
cell types to understand how they contribute to the aging and disease processes and address their mechanistic
implications, including an explicit test that Aβ triggers tauopathy in hippocampal cell types. The enhancer AAVs
will express genetic payloads including fluorescent reporters, optogenetic and chemogenetic tools, calcium
indicators designed to map and manipulate brain cell subtypes including neuronal and non-neuronal cell types.
We will conduct neural circuit manipulation and mapping experiments including cell-type-specific viral tracing, in
vivo structural and functional imaging and behavioral experiments to validate our proposed hypothesis.

Public health relevance
Project Narrative Alzheimer's disease (AD) is a major health concern in the United States. The proposed research will optimize and use cell-type-selective enhancer AAV tools to study vulnerable cell types and disease-relevant neural circuits using mouse models of aging and AD. Our proposed research meets the goal of RFA-AG-25-024 and will help us understand the cellular and neural mechanisms underlying aging and AD/ADRD.